Fibrosis: Inflammation, Drivers, and Therapeutic Resolution

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Fibrosis: Inflammation, Drivers, and
Therapeutic Resolution, organized by Drs. Valerie Horsley, Michael Longaker and Thomas Wynn. The
conference will be held in Whistler, BC, Canada from December 8-12, 2024.
Fibrosis is characterized by aberrant fibroblast activation and inadequate tissue repair. Fibrosis is a common
end-stage pathology in all major internal organs and solid tumors causing 45% of deaths in Europe and North
America. While advances have been made in the understanding of molecular mechanisms driving tissue injury
and fibrosis, there remains a need to identify targets/pathways that are relevant to human disease and can be
leveraged to promote repair and regeneration, as well as to develop translational strategies to facilitate clinical
development of novel therapies. This long-standing symposium series will serve as an engaging platform for
world-renowned researchers across the globe, both early-career and established, to exchange ideas, showcase
pioneering findings, and foster fruitful collaborations on topics of clinical innovations, immunobiology, and
mechanobiology in the field of fibrosis research. The program will include workshops on multiomics approaches
and lessons learned across tissues, as well as poster sessions, and informal activities to facilitate community
building and in-depth discussions. Additionally, the conference will provide unparalleled opportunities for
mentoring, training, and interactive scientific exchanges. With its wide-ranging scope of topics and unique
opportunities for cross-industry and multi-disciplinary collaborations spanning different organ systems, no other
meeting in this area rivals the comprehensive platform offered by this Keystone Symposia conference.

Public health relevance
PROJECT NARRATIVE Fibrosis is a common clinical complication resulting from injury or disease and is responsible for numerous deaths each year. Despite advances in our scientific understanding of fibrosis, there remain gaps in our knowledge that need to be addressed to facilitate clinical development of new therapies for patients. This Keystone Symposia conference continues to serve as an engaging platform for researchers from across the globe to exchange ideas, showcase pioneering findings, and build lasting collaborations focused on clinical innovations, immunobiology, and mechanobiology in the field of fibrosis research.